Synthesis of Biologically Active Terpenoids

PROJECT SUMMARY
Natural products continue to be one of the most important sources of new lead compounds for the discovery
of medicinal agents. They occupy vast regions of chemical space, providing much greater diversity in their
structures as well as their biological properties compared to those of classical drug molecules. Potent
compounds from nature have provided paramount architectural inspiration for developing new chemical
therapies, with more than 80% of all drugs and over 65% of anticancer drugs being, derived from, or inspired by
natural products; however, their structural complexity and limited availability are often the sole obstacles
preventing their further study and clinical development. As synthetic organic chemists situated at the interface of
chemistry and biology, our research program is devoted to providing solutions to this supply problem in the form
of sustainable and practical syntheses of complex biologically active natural products, and to performing
fundamental studies of their chemical biology. By developing new synthetic strategies, as well as target-specific
methodologies, we intend to provide efficient access to complex bioactive natural products and bring them within
the realm of medicinal chemistry. Specifically, in this proposal we describe synthetic approaches to several
diverse terpenoid natural product classes: isomalabaricane triterpenoids, nimbolide, and a vast range of
perhydrobenz[e]indene-based terpenoids. We already established stereodivergent access to all four challenging
stereoisomers of the rare 6/6/5 tricyclic terpenoid core structure that occurs in nature. Moreover, we recently
completed several isomalabaricanes, using synthetic blueprint that permits rapid diversification. We are
beginning to engage in biological investigations, and our ongoing collaboration with chemical biology experts will
provide an excellent opportunity to test these compounds and their analogues for therapeutic activities, as well
as to elucidate their mechanisms of action, molecular targets, and metabolites. It is expected that these studies
will provide anticancer and anti-infective agents with unprecedented molecular topologies and functions, as well
as advance our basic knowledge of their mechanistic specificity for certain cancers and pathogenic diseases.

Public health relevance
PROJECT NARRATIVE Natural products hold a crucial role in developing novel molecular tools, such as pharmaceutical agents and probes. Specifically, they provide a major driving force for discovering new chemotherapeutics and are the primary source of compounds for the effective treatment of cancer and infectious diseases. The proposed research aims to develop new strategies and methods to prepare and study promising small bioactive molecules based on complex natural products that are not readily accessible yet would be highly desirable if brought within the realm of medicinal chemistry.